Dynamic manifold-valued time series model in functional brain imaging

Abstract
We will develop new large-scale dynamic models of manifold-valued data with a focus on dynamic
symmetric positive deﬁnite (SPD) structures from nonstationary multivariate time series obtained
from human functional magnetic resonance images (fMRI). The proposed new models and meth-
ods will capture how functional brain connectivity dynamically changes over time and thus will
be used to more accurately evaluate evolutionary dynamics of functional brain networks at the
voxel level. We propose to build dynamically changing functional brain networks from a dataset
with 1206 subjects from the Human Connectome Project (HCP) database containing T1-weighted
magnetic resonance images (MRI), diffusion tensor images (DTI) and task and resting-state fMRI.
MRI and DTI will be used in conjunction with fMRI in building more reﬁned dynamic connectivity
models. We will determine network phenotypes speciﬁc to behavior and their genetic associations.
This study will provide the research community with the baseline brain network heritability maps
as well as a versatile open-source toolbox of algorithms for modeling and visualizing dynamically
changing large-scale brain networks.

Public health relevance
Project Narrative The goal of this study is to develop algorithms and open-source software for building large-scale dynamic models of brain networks using fMRI of 1206 subjects available from the publicly available Human Connectome Project (HCP) database. The proposed algorithms will be used to establish the baseline map for the genetic inﬂuences on brain networks at the voxel level. Considering recent surge of interests in dynamic brain network phenotypes in relation to behavior and genetics, such detailed heritability maps will be highly useful as a baseline for future studies.